California National Primate Research Center

OVERVIEW
ABSTRACT
The California National Primate Research Center (CNPRC), located at the University of California, Davis,
requests funds to renew the base operating grant #P51-OD011107 for the next five year period (May 1, 2018
through April 30, 2023). Currently in the 56th year of operation, the CNPRC serves a range of NIH-supported
investigators and industry partners nationwide. From inception through the current year, the CNPRC has been
highly responsive to the research community by providing high quality animals, facilities, tools, and services
driven by the intellectual infrastructure of the Core Scientists in the service of our Mission: “To improve human
health and quality of life through support of exceptional nonhuman primate research programs”. The goals for
the next funding period are reflected in the following Specific Aims: (1) Conduct state-of-the-art research and
scientifically contribute to the understanding and treatment of human disease with nonhuman primate models
across the age spectrum, (2) Provide exceptional nonhuman primate expertise and services to investigators at
the local, regional, and national levels to advance NIH-supported research excellence, (3) Mentor and train the
next generation of translational investigators with nonhuman primate expertise, and (4) Ensure the highest
standards of responsible conduct of research and animal care. We will continue to emphasize team science
aimed at major human health problems across the lifespan, with the goal of moving beyond traditional
interdisciplinary efforts to true convergence on the research problems being addressed. Support is requested for
Administrative Services (Director's Office, Administration and Operations Services, Information Technology
Services, Facilities Improvement), Primate Services (Colony Management and Research Services, National
Institute on Aging Colony, Primate Medicine Services, Anatomic and Clinical Pathology Services, Population and
Behavioral Health Services, Genetics Management Services), Service Cores (Flow Cytometry, Inhalation
Exposure, Multimodal Imaging, Primate Assay Laboratory), Scientific Research Units (Infectious Diseases,
Neuroscience and Behavior, Reproductive Sciences and Regenerative Medicine, Respiratory Diseases), and for
Outreach, the Pilot Research Program, and NPRC Consortium activities. Our over-arching goal is to achieve
translational impact through preclinical programs housed at the CNPRC as well as through collaborative teams
that reach out locally, nationally, and globally. We are committed to developing and providing a wide range of
research opportunities that maximize use of the nonhuman primate model to improve human health. The
institutional commitment from UC Davis to the CNPRC has been reinforced in a manner that will facilitate our
role in moving nonhuman primate research into the next era of convergent biomedical research.

Public health relevance
OVERVIEW NARRATIVE The CNPRC is an established national resource that has as a primary mission to improve human health and quality of life through support of exceptional nonhuman primate research programs that advance our knowledge of the causes, preventions, treatments, and cures of debilitating diseases. This mission is pursued through robust and well-developed on-site research programs, facilities, and expertise that are significantly augmented by collaborative programs that serve the greater biomedical research community.